Smooth muscle cell PRDM16 and aortic aneurysm

Project Summary/Abstract
Aortic aneurysm (AA) is an asymptomatic disease with high mortality rate (65% to 85%) if rupture occurs.
Repair through open or endovascular surgery is currently the only therapeutic option for aortic aneurysm. No
drug has been approved for the treatment of this devastating disease. While surgical intervention is effective in
preventing rupture, it is however often associated with surgical complications that result in severe morbidity
and even mortality. Thus, AA is still a life-threatening disease. Unfortunately, the mechanisms underlying
aneurysm development are largely unknown, which is limiting development of medications for treatment of
aneurysms and dissections. This highlights an urgent need for better understanding of aneurysm formation and
progression. PR domain containing 16 (PRDM16) is a transcriptional regulator and plays crucial roles in the
determination and development of cells including hematopoietic, cardiomyocytes and smooth muscle cells.
Prdm16 germline or vascular smooth muscle cell (VSMC) selective knockouts are embryonic lethal in mice,
highlighting the importance of PRDM16 in the developmental processes of VSMC. It is not yet known whether
PRDM16 in VSMC will affect the development of abdominal aortic aneurysm (AAA). Our preliminary data
indicate that PRDM16 is significantly reduced in aorta of AAA patients and the PRDM16 SNP is associated
with human AA rupture. Tamoxifen-induced VSMC-selective Prdm16 knockout in mice results in a significant
increase in elastin degradation in AAA lesions. These data suggest that loss of PRDM16 function promotes
AAA formation. We further uncovered that PRDM16 negatively regulates expression of transforming growth
factor β (TGF-β) and A disintegrin A metalloprotease 12 (ADAM12) in VSMC. TGF-β induces ADAM12
expression which is positively correlated with cell apoptosis. Additionally, conjugated linoleic acid (cLA) is an
omega-3 derivative that serves as the preferential endogenous substrate of nitration. Interestingly, oral delivery
of cLA and inorganic nitrite (NO2) yields endogenous nitrated cLA (NO2-cLA). NO2-cLA is a next generation
nitro-fatty acid and the most abundant endogenously produced in humans. Our preliminary data document that
NO2-cLA stabilizes PRDM16 protein and protects against AAA formation and progression in vivo. Also, NO2-
cLA inhibits VSMC apoptosis and inflammation, two hallmarks of AAA, in a PRDM16-dependent manner.
Therefore, we will specifically and systematically address the central hypothesis that “endogenous production
of NO2-cLA protects against AAA formation and progression through PRDM16 in VSMC”. The specific aims of
this proposal are to: 1) determine that PRDM16 in VSMC prevents AAA formation and progression; 2)
determine that PRDM16 protects against VSMC dysfunction through inhibition of TGF-β/ADAM12 signaling;
and 3) determine that endogenous production of NO2-cLA protects against AAA through PRDM16 in VSMC.
This work will define PRDM16 as a novel therapeutic target for AAA and establish the basis to develop a
feasible new oral therapeutic approach..

Public health relevance
Project Narrative Aortic aneurysm is a major medical concern due to the increasing prevalence and high mortality rate. The pathophysiology of this disease is largely unknown which limits the development of drug targets. The proposed project is relevant for public health because it will establish a novel therapeutic target aimed to manage this asymptomatic disease with a high mortality rate.